IDENTIFICATION OF CARBOHYDRATE INTOLERANCE DURING PREGNANCY

This protocol is utilized as an identification program for pregnant women with carbohydrate intolerance. The intravenous glucose tolerance test is no longer used, having been replaced by a three hour GTT following a 100 g glucose load.